High-Resolution Ground-Level AQ Monitoring System Using Hyper-local Low-cost Sensor Nodes and AI Forecasting

PROJECT SUMMARY/ABSTRACT
This grant application directly addresses the mission objectives of NIEHS, specifically “Sensors and Other
Exposure Assessment Tools”, providing innovative pollutant sensor and AI modelling technologies integrated
into wearable devices. We propose demonstrating a truly low-cost sensor node to monitor TPRH, CO, VOCs,
and OX (NO2+O3) in the base unit. This node will contain a climate (TPRH) sensor plus revolutionary printed
amperometric gas sensors (AGS) developed under prior work. PM, NO2, O3 and SO2 will be available low-cost
options. To compensate for environmental effects, aging/drift and cross-sensitivity exhibited by all amperometric
gas sensors, the data will be analyzed by an on-board µ-processor using smart algorithms and machine learning
(edge-computing). The data transmitted by these nodes will be analyzed in real-time, integrated with data from
all other sensors connected to the data platform, and presented on the dashboard. Not only will the resulting
technology provide much more accurate data from these very low-cost nodes, but with all sensor data processed
and consolidated at the source, much more efficient transfer to data platform with greatly reduced bandwidth
requirement is possible. This will allow more comprehensive data analysis, creating the opportunity for real-time
chemical modelling to predictively map AQI and pollutant levels in advance to allow people to respond and
prepare any needed mitigative measures.

Public health relevance
Project Narrative Exposure assessment provides multi-disciplinary strategies and methods to anticipate, recognize, evaluate, control, and confirm effective management of occupational health stressors, exposures to those stressors, and resulting health risks. Existing air quality models are poor-resolution and reactive, using data largely from stations such as EPA reference stations which are expensive, widely separated and located primarily in cities and suburban areas. We seek to improve air quality models to reduce exposure to pollutants such as ozone and NOx by developing a new technology integrating reliable, hyper-local low-cost air quality nodes combined with data fusion and AI-enabled predictive AQI modelling to provide a widely accessible data platform and map dashboard.